Linking the dopaminergic mechanisms of reinforcement learning and timing

Project Summary
The ability to keep track of elapsed time is essential for many forms of reward-guided learning and behavior.
Midbrain dopamine (DA) neurons are implicated in both reinforcement learning (RL) and timing, however, these
two functions have largely been studied in parallel rather than under a unified framework. One of the most elegant
demonstrations that DA dynamics contain timing information is found in trace conditioning tasks, when reward
is unexpectedly omitted. This form of negative reward prediction error appears as a brief inhibition, or dip, in DA
activity around the time of expected reward. While this DA dip is usually interpreted as a negative reinforcement
signal, it also represents a highly effective neurophysiological readout of predicted reward timing. However,
despite being a well-known phenomenon, it is still unclear how DA neurons learn to predict the timing of reward.
This project seeks to address this significant gap in understanding by studying the neural circuit mechanisms
underlying the timing of the DA reward omission dip. We will examine the role of DA signals and neural dynamics
in the ventral striatum, an area implicated in reward and temporal processing. The project’s central hypothesis
is that DA and striatal timing processes are interdependent, with the striatum relying on DA signals to learn a
more refined representation of time, and DA neurons relying on this striatal code in order to predict the timing of
reward, and thus undergo properly timed dips if reward is omitted. The project will combine experimental and
computational approaches to measure, perturb, and model DA, striatal dynamics, and licking behavior in mice
engaged in classical trace conditioning tasks, with rewards omitted on a subset of trials in order to probe timing
processes. Aim 1 will examine how the temporal precision of DA reward omission dips and striatal dynamics
changes across learning. This will provide a crucial test of the prediction that the representation of time in these
circuits is a plastic property and not fixed, as assumed by most reinforcement learning models. Additionally, this
will reveal whether specific striatal populations, namely either D1 or D2 receptor expressing projection neurons,
become better at encoding time over the course of learning. Aim 2 will pursue causal evidence that DA and
striatal dynamics mutually influence each other’s temporal coding properties, by transiently manipulating activity
in one circuit and monitoring changes in the temporal precision of the other circuit. Here we will also determine
whether these manipulations alter the temporal precision of licking behavior. Last, Aim 3 will seek to develop a
computational framework for describing the experimental results. We will build and test predictions of temporal
difference reinforcement learning (TDRL) as well as biologically inspired recurrent neural network models
constrained by experimentally observed data. Taken together, this highly synergistic experimental and
computational effort is expected to lead to a more unified understanding of the mechanisms underlying RL and
timing.

Public health relevance
Project Narrative The ability to predict the timing of upcoming rewards is a critical aspect of behavior, but little is known about how the mechanisms underlying timing and reward-based learning are linked. The goal of this project is to examine how animals are able to learn to predict the timing of rewards by studying interactions between two brain circuits. This work is expected to provide new insights about the fundamental basis of reward learning and prediction, which is disrupted in several disorders including addiction.